IMMUNOPATHOLOGY OF OCULAR DISEASES

Ocular specimens from human ocular tissues with various diseases, such as uveitis, conjunctival and corneal diseases, and ocular metabolic genetic diseases were studied using immunoperoxidase technique as well as light and electron microscopic evaluation. In uveitis, immunocompetent cells and lymphokines are critical in the reflection of clinical diagnosis, course and prognosis. In non-uveitis, alteration of cellular membrane surface markers and intracytoskeleton on the ocular resident cells may imply damages and abnormalities in these diseases.